The role of glucocorticoid receptor in the ovary

Abstract
Ovarian disorders in women, including defects in ovulation and subsequent corpus luteum development,
account for up to 30% of all infertility cases. Understanding the mechanism underlying these processes is
critically important because this knowledge serves as a foundation for our ability to aid or manage female
fertility. Glucocorticoids (GCs) are potent hormones involved in various cellular functions, including
inflammatory responses and cellular metabolism, which are also hallmarks of the ovulatory process and luteal
development. In the ovary, the level of cortisol, an active glucocorticoid, dramatically increases in the follicular
fluid after an ovulatory human chorionic gonadotropin (hCG) stimulation in women and monkeys, whereas the
level of cortisone, an inactive form, rapidly decreases. Our recent studies and preliminary data demonstrated
that the administration of an ovulatory bolus of hCG increased the expression of crucial components required
for cortisol production and action in granulosa cells of periovulatory follicles in normally cycling women,
monkeys, and mice. Moreover, our experimental data indicate that GCs/glucocorticoid receptor (GR) plays
critical roles in cumulus expansion, ovulation, and luteal development. However, little is known about the
mechanisms by which GCs/GR regulate these processes and their physiological significance in the ovary. The
present proposal will address these critical questions by utilizing experimental models from three key species
to gain a comprehensive understanding of the role of GCs/GR in the pivotal process in the ovary. In Aim 1,
using transgenic mouse models in which GR expression is ablated in ovarian follicular cells, we will determine
the physiological significance of GR and identify GR-mediated transcriptomic, genomic, and functional changes
necessary for successful ovulation and luteal development. In Aim 2, we will utilize adult female rhesus
monkeys to demonstrate that the inhibition of GR in preovulatory follicles negatively affects ovulation and luteal
development and determine the specific function(s) and transcriptomic regulation affected by GR inhibition. In
Aim 3, using dominant preovulatory follicles obtained from normally cycling women across the ovulatory period
and primary human granulosa/lutein cells, we will delineate the mechanisms by which GCs/GR signaling
regulates ovulatory changes and luteinization by first identifying direct downstream target genes of GR in
primary human granulosa cells, then characterizing their expression in dominant follicles during the ovulatory
period, and lastly assessing functional impacts of GR inhibition. By demonstrating the physiological
significance and identifying specific actions of GCs/GR in the periovulatory ovary across multiple species, the
proposed study will provide novel insights into the species-specific and -conserved mechanism controlling
ovulation and luteinization. This fundamental knowledge will be valuable for developing strategies to assist
women experiencing infertility due to anovulatory disorders and luteal insufficiency.

Public health relevance
Narrative Successful ovulation and subsequent corpus luteum development are essential for female fertility. In the present proposal, we will demonstrate for the first time that glucocorticoids/glucocorticoid receptor plays critical roles in ovulation and corpus luteum development in mice, monkeys, and humans. This fundamental Information will not only provide novel insights into the mechanism(s) underlying ovulation and luteal formation but also be valuable for developing strategies to assist women with compromised reproductive health and infertility stemming from defects in the ovulatory process and luteal development.